Ancient viral threats through the lens of adaptation in human genomes

Project Summary
The current SARS-COV2 pandemic has brought to light that more efforts are needed to evaluate the pandemic
potential of viruses that can spill over in human populations. To assess the pandemic potential of specific
viruses, over the next five years my lab will ask if similar viruses caused epidemics not only during the recent
documented past, but during the much longer time scale of human evolution. Viruses that caused epidemics in
the past are indeed the most likely to cause epidemics again in the future, and hundreds of viral epidemics
likely plagued human populations during their evolution. This work will fill gaps in knowledge on epidemics in
ancestral human populations, and by doing so, will enable a better assessment of the viruses that represent a
future pandemic threat.
To study ancient epidemics, my lab will exploit host genomic adaptation driven by ancient viruses.
Arms races with viruses have shaped the host immune system by driving a large number of adaptations. I
recently showed that viruses left abundant signals of adaptation not only in immune genes, but across the
entire human genome. The lab will examine signals of adaptation left by specific viruses in human genomes, to
detect, date, and functionally characterize ancient epidemics. To this aim, we will develop new statistical tools
based on recent advances in machine learning and in the reconstruction of Ancestral Recombination Graphs
(ARGs). These new approaches with increased power to detect and date genomic adaptation will allow us to ask
the following questions:
1) Which viruses drove ancient epidemics in human evolution?
My lab will create deep learning tests with high power to detect complex genomic adaptation within the past
~200,000 years of human evolution.
2) When did specific viruses drive ancient epidemics?
We will use ARGs and Approximate Bayesian Computation to date ancient epidemics, by dating the host
adaptive events driven by specific viruses.
3) Which functional host genetic changes were selected during ancient epidemics, in which
genes, and how do they influence genetic susceptibility to present viruses?
We will investigate regulatory adaptation to viruses and the overall impact of virus-driven host adaptation on
the genetic susceptibility of different human populations to specific present viruses, thereby providing
virologists with strong candidate host genes for further inquiry.
My lab is uniquely suited to decipher ancient epidemics by linking host-pathogen interactions together
with the latest developments in the population genomics of adaptation.

Public health relevance
Project narrative Arms races with viruses have shaped human genomic adaptation, not only in immune genes, but also across the entire human genome. Over the coming years, my lab will exploit host genomic adaptation to detect, date, and functionally characterize ancient viral epidemics that plagued ancestral human populations. Because past viral threats are more likely to become threats again in the future, ancient epidemics will provide a better assessment of the viruses with the potential to cause future epidemics.